PRIDE-Functional and Translational Genomics of Blood Disorders

Abstract
The lack of diversity remains a significant challenge in biomedical and behavioral science research programs
and faculty composition in US academic centers. The National Heart, Lung, and Blood Institute (NHLBI) funded
the Summer Institute Program to Increase Diversity (SIPID) in 2006. Subsequently, the Program to Increase
Diversity Among Individuals Engaged in Health-Related Research-Functional and Translational Genomics of
Blood Disorders (PRIDE-FTG) was established at Augusta University. Through the PRIDE-FTG program, we
provided mentored training for 76 underrepresented minority junior faculty investigators. Mentees learned
hands-on bench research and grantsmanship skills during two consecutive Summer Institutes. Program
evaluation supports the achievement of our primary goal of aiding mentees to submit an NIH or equivalent
grant application within two years of program completion, demonstrated by a 41.7% NIH grant-funding rate as
principal investigator. We propose to continue this mentored training with the next iteration of PRIDE-FTG,
expanded to include several innovative components and collaboration with the Obesity Health Disparities-
PRIDE program to pool federal resources. We will test the hypothesis that a mentored training program to build
research and grant-writing skills will increase the ability of URM and disabled faculty, conducting blood
disorders research to obtain extramural funding and transition to independent research careers. Four aims will
be accomplished: AIM 1. Conduct Innovative Summer Institute 1 at Augusta University (Component 1).
Mentees matriculating into the PRIDE-FTG program will participate in a multidisciplinary curriculum including
hands-on-bench research training and grant-writing activities to develop funding strategies. AIM 2. Support
Small Research Project Funding Initiative (Component 4). In collaboration with the PRIDE Steering Committee
and NHLBI program staff, the PRIDE-FTG program will fund focused pilot projects to support competitive grant
proposals addressing blood disorders research. AIM 3. Facilitate Mentoring and Networking Activities
(Component 2). Mentorship Committees comprised of a mentee, a PRIDE research mentor and home
institution mentor will be established. Peer-mentorship teams will launch within cohorts to promote research
collaboration. The program will support a mid-year visit to the mentor’s institution and attendance at the
consortium-wide PRIDE annual meeting. AIM 4: Conduct Innovative Summer Institute 2 (Component 3).
Mentees will return to Augusta University to complete a one-on-one grant review to meet the primary goal of
the PRIDE program to submit an NIH or equivalent grant application and participate in additional research
experiences. The mentored training supported by the PRIDE-FTG program will influence the number of
underrepresented and disabled scientists achieving successful biomedical research careers.

Public health relevance
Project Narrative The lack of diversity among the US biomedical research workforce remains a significant challenge. However, it is clear that expanding research technical skills combined with novel mentoring approaches are essential components of programs seeking to increase diversity. The Program to Increase Diversity Among Individuals Engaged in Health-Related Research-Functional and Translational Genomics of Blood Disorders, at Augusta University will address these challenges by providing intensive mentoring and research experiences in functional and translational genomics, to develop competitive research projects, NIH funding and increase diversity of the US biomedical workforce.